Vaccine immunity and inflammation in the aging person living with HIV

Persons living with HIV (PLWH) are at increased risk of chronic inflammation and the associated adverse
health outcomes. There is considerable evidence that chronic inflammatory conditions like metabolic disease
and autoimmune disorders are associated with weakened vaccine responses and existing vaccine studies in
PLWH do not adequately sample older individuals who are disproportionately affected by this “inflammaging.”
We hypothesize the effect of age on poor vaccine responses is greater among PLWH given the additional
burdens of HIV driven inflammation. The overall project goal is to examine this premise by measuring the
impact of HIV status, age, and chronic immune activation on conjugate pneumococcal vaccine responses. We
will study acute (30 day) and longer-term (2 year) immune responses following PCV20 vaccination, among a
cohort of participants including 4 groups: a) older PLWH, age ≥50 (n=100), b) older HIV uninfected controls,
age ≥50 (n=50), c) younger PLWH, age <50 (n=50), d) younger HIV uninfected controls, age <50 (n=50). With
these cohorts, we will 1) Comprehensively characterize the impact of HIV and age on the
immunogenicity of conjugate pneumococcal vaccination by longitudinally tracking adaptive vaccine-
specific antibody, B cell and CD4 T cell responses. We will compare these responses by age and HIV
status. We will also 2) Determine the influence of chronic inflammation on vaccine-specific immunity
among PLWH across the adult lifespan by measuring the associate between vaccine immunity and
biomarkers of chronic inflammation. This project will provide valuable knowledge on how HIV and age
influence vaccine immune responses with the hope of informing vaccine development and schedule to
optimize the long-term health of persons living with HIV.

Public health relevance
This project will examine how HIV and age influence the immunogenicity of pneumonia vaccines (how well the immune system is stimulated by these vaccines) with the goal of determining whether specialized approaches are needed to vaccinate individuals living with HIV in advancing age who are on anti-retroviral treatment. It will further examine whether chronic inflammation in persons living with HIV is associated with impaired vaccine responses.